CORE--BEHAVIORAL SCIENCE

Description: The Behavioral Science Core (BSC) was established approximately three years ago as a replacement and extension of the previous Media Services Core. Current objectives are to 1) provide common audio-visual recording and behavioral coding facilities, 2) provide statistical consultation services, 3) provide graphic consultation services and facilities, and 4) establish a new technical consultation service to support current and extended research on brain-behavior relations, particularly with regard to psychophysiological techniques.